CHANGES/INFUSIONS OF ADENOSINE, DOPAMINE AND NORMAL SALINE

This study will evaluate the ability of a portable, non-invasive Renal Function Monitor to detect acute changes in GFR. The Renal Function Monitor has been validated in healthy volunteers during steady-state within the GCRC. This project evaluates its ability to detect acute changes in GFR induced by known physiologic/pharmacologic challenges. The accuracy of this monitor will be determined by comparing with inulin and DTPA plasma transcutaneous clearances.